UNDERSTANDING THE ROLE OF ALTERNATIVE SPLICING IN THE TNFAIP3 SLE-RISK ALLELES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. It has recently been discovered that certain genetic variants confer increased risk of developing SLE. This project will define any alternate splicing patterns that may arise from these risk haplotypes, both at rest and under stimulated conditions, and will determine the relative abundance of these alternate transcripts.